AI HazMat Specialist for Supplemental Learning

Project Summary/Abstract
It can be difficult to master all the concepts related to hazardous materials training
independently, even while having access to the Emergency Response Guidebook (ERG) and
NIOSH Pocket Guide to Chemical Hazards (NPG). Classes cover general knowledge but
sometimes it would be better to ask a HazMat specialist what their course of action would be in
specific scenarios. It takes years of experience to be able to think on your feet in an emergency
situation, and personnel new to the field may not be confident or quick in their decision making
in a time of crisis.
This work aims to create an Artificial Intelligence (AI) model to become an unparalleled
HazMat specialist. This AI model will be trained extensively on the ERG, NPG, HAZWOPER
lesson documentation, and many other trusted HazMat resources, and then further refined with
direct information from HazMat industry veterans. Users will be able to ask HazMat questions
and receive detailed responses to promote the safety of HazMat workers and protection of life
and property. The AI will supplement any HazMat training by providing an extra resource to ask
questions and find accurate information on actions necessary regarding a hazardous materials
emergency. Responses will be focused on the standards set forth by 29 CFR 1910.120.

Public health relevance
Project Narrative A HazMat specifically trained AI model would provide HazMat workers and students an extra resource to acquire potentially lifesaving information. Being able to freely ask HazMat related questions without an instructor or specialist available would bolster the knowledge of workers and students and allow for better independent learning. AI could give the workers and students the tools they need to be confident in their decision making in an emergency situation.